Neutrophils in polytrauma – from recruitment to phenotypic and functional reprogramming

Abstract:
My long-term goal is to determine the mechanisms that regulate neutrophil response in health and disease and
how they are altered by the presence of chronic low-grade systemic inflammation. Traumatic injuries are a
leading cause of death and disability in younger people being a major public health problem worldwide.
Neutrophils are known for their fast and moldable inflammatory response upon injury, which are massively
recruited after trauma. Neutrophils play a crucial pathological role in the complex systemic inflammatory
response that leads to life-threaten situations. Patients with chronic low-grade systemic "metabolic" inflammation
display a dysregulated neutrophil response and function. Consequently, these patients are at high risk of
developing serious complications and exhibit a high mortality rate after trauma. Knowledge of how
metainflammation impacts neutrophil response in polytrauma is limited, particularly in what concerns the
regulatory mechanisms that coordinate and direct neutrophil recruitment to sites of concurrent traumatic injuries.
Trauma affects the phenotype and function of neutrophils, which impairs the neutrophil capacity to fight infections
while at the same time promotes tissue damage phenotypes that contribute to the overall immune dysfunction.
These alterations on neutrophil populations set the stage for secondary inflammatory complications such as
sepsis, multiple organ failure (MOF), and nosocomial infections that delay recovery and can lead to disability or
death. It is also unclear how traumatic injury sites reprogrammed neutrophils and if it is dependent of trauma
localization, or the patient’s overall inflammatory status. In this MIRA application, we plan to investigate
mechanisms involved in neutrophil phenotypic and functional modulation in polytrauma. We will take advantage
of the remarkable zebrafish animal model known for its optical transparency and ease of genetic and
pharmacological manipulation to visualize, track and deconvolute the molecular mechanism involved in the
neutrophil response in polytrauma at a whole-animal context. We will combine our zebrafish polytrauma model
and unique whole-animal non-invasive live imaging approach with genetic manipulation and protein, lipid,
transcript, and epigenetic profiling of neutrophils and concurrent traumatic injury sites to evaluate 1) the
regulatory mechanisms that coordinate neutrophil recruitment to concurrent traumatic injuries, 2) how neutrophils
are reprogrammed at sites of traumatic injury to generate specific neutrophil subsets that reverse migrate and
disseminate inflammation in trauma, and 3) how chronic inflammation impacts such processes. Our research
will allow us to gain a deeper understanding of the neutrophil mechanisms involved in polytrauma inflammatory
response in healthy and metainflammation settings. The knowledge achieved by the proposed research will
enable us to manipulate neutrophil response as a means by which to improve patient outcomes following trauma,
particularly in high-risk groups.

Public health relevance
Project Narrative: Trauma is a major public health crisis worldwide, and the number one leading cause of death from age 1 to 46. Neutrophils play a crucial pathological role in posttraumatic inflammatory response. Importantly, dysregulation of neutrophil responses and function due to pre-existent metabolic syndrome and associated metainflammation, contribute to increased susceptibility to develop posttraumatic complications in high-risk groups. Therefore, the goal of this work is to determine the mechanisms governing neutrophil responses in polytrauma in healthy and metainflammation conditions.